NIDDK Office of Fellow Recruitment and Career Development

The Fellowship Office continues to carry out its broad portfolio of activities directed at improving the overall research experience of our Fellows. Through collective efforts with the Fellows Advisory Board, we carried out another very successful Annual Fellows Scientific Conference in April 2016. This two-day research and career development-oriented meeting provided an opportunity for our Postdoctoral, Clinical, and Predoctoral Fellows to share their research findings with other young scientists at our Institute. The goal is to promote cross-fertilization of ideas, develop new research collaborations, exchange technical knowledge, and foster a sense of community among the Fellows. All fellows had the opportunity to present their research projects and interests as either oral or poster presentations; approximately 120 participated this year. Many of the sessions at the Conference focused on career management and academics. There were a number of sessions concentrating on the different aspects of developing a scientific career, both at and away from the bench. We also held panel discussions featuring recent NIDDK Postdoctoral Alumni who shared their personal experiences about life in their new job settings. This past year was also notable for the popular and widely attended Grant Writing Workshops and for the Nancy Nossal Fellowship Award cycles that continue to provide Fellows with a real-world grant writing experience.